Posttranslational control of VSMC identity and vascular health

The phenotypic switching of vascular smooth muscle cells (VSMCs) from a contractile to a proliferative state is
critical in the development of occlusive vascular diseases, such as coronary artery disease (CAD). This process
is traditionally understood to be regulated by transcriptional mechanisms involving the serum response
factor/myocardin (SRF/MYOCD) transcriptional complex. However, the role of protein post-translational
modifications in this process remains largely unexplored. This application aims to determine the significance of
neddylation, an emerging ubiquitin-like protein modification, in VSMC homeostasis and vascular health.
Neddylation involves the attachment of one or more NEDD8 moieties to protein substrates through a NEDD8-
specific enzymatic cascade, with NEDD8 activating enzyme 1 (NAE1) playing an indispensable role. Recent
preclinical and animal studies have demonstrated neddylation's importance in embryonic development, organ
homeostasis, and tumorigenesis. Despite this, the role of NAE1-mediated neddylation in smooth muscle biology
remains poorly understood. Preliminary data reveal associations between NAE1 variants and cardiovascular
events in humans. Deleting Nae1 in pan-SMCs of neonatal or adult mice results in severe visceral myopathy
and premature death due to a pseudo-obstructive intestinal condition, suggesting the importance of neddylation
in visceral SMCs. To further investigate neddylation in adult VSMCs, we developed inducible VSMC-specific
NAE1 knockout mice. These mice exhibited significant vascular remodeling at baseline, including aneurysmal
dilation, elastin lamina distension and breaks, collagen deposition, and spontaneous coronary artery remodeling.
Additionally, under hypercholesterolemic conditions, the mutant mice developed advanced lesions with thin caps
in coronary arteries and thoracic aortae-areas typically resistant to lesion formation, ultimately leading to death
a few months after high-fat diet feeding. These striking vascular phenotypes underscore the previously
unrecognized role of VSMC neddylation in vascular health and disease and highlight the imperative need to
elucidate the underlying mechanisms. Guided by our preliminary data, we hypothesize that protein neddylation
preserves VSMC homeostasis by maintaining the contractile gene program and preventing cell death. To test
this, we propose two aims. Aim 1 will explore how neddylation regulates the SRF/MYOCD axis to establish and
maintain the VSMC contractile phenotype at baseline. Aim 2 will investigate how neddylation controls VSMC
metabolism and suppresses VSMC ferroptosis to prevent lesion formation in both large and small arteries under
hypercholesterolemic conditions. Unique genetic mouse models, pharmacological inhibitors, multi-omics,
lineage tracing reporters, and sophisticated biochemical and molecular analyses will be used to rigorously
examine the proposed mechanisms in vitro and in vivo. Completing the proposed studies will uncover the
mechanisms controlling VSMC phenotypic plasticity and create opportunities to target VSMC neddylation to
prevent and treat vascular diseases.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the number one cause of mortality in the US. The proposed study focuses on investigating the function and the underlying mechanisms of neddylation in vascular smooth muscle cells. Identification of the key players such as NAE1 in regulating smooth muscle phenotype will provide the foundation for treating or preventing smooth muscle-driven diseases in cardiovascular system.